Role of sulfide in oral microbiota-host interactions that promote periodontitis

PROJECT SUMMARY/ABSTRACT (for administrative supplement to parent R00 award from NIDCR)
Periodontal (gum) disease is one of the most prevalent inflammatory diseases worldwide, affecting nearly 50%
of adults in the US alone. Untreated, periodontitis can erode the tissues that support the teeth, ultimately resulting
in tooth loss, as well as increased risk for several co-morbidities (e.g., diabetes, heart disease, and cancer). In
contrast to classic infectious diseases, periodontitis is triggered by the outgrowth of multiple (rather than
individual) “pathogens” - pro-inflammatory, normally low-level constituents of the oral-cavity microbiota. These
pathogens expand by metabolically exploiting local tissue damage, while also excreting metabolites that sustain
further inflammation. A key example is hydrogen sulfide. This pro-inflammatory metabolite is produced in prolific
amounts by periodontal pathogens, due to their increased access to tissue damage-derived, sulfur-containing
amino acids - cysteine, methionine, and taurine. In our funded parent award (R00 through NIDCR), we focus on
cysteine/methionine and a particular mechanism by which their degradation to sulfide, specifically by the
pathogen Fusobacterium nucleatum, can potentially exacerbate periodontitis: inflammation triggered by F.
nucleatum-derived sulfide constructs a metabolic niche that enables expansion of a prominent co-pathogen
(Aggregatibacter actinomycetemcomitans). Unlike F. nucleatum, other pathogens within the oral microbiota can
degrade taurine. Yet, whether sulfide from taurine-degrading pathogens can also contribute to periodontitis has
not been explored. This is particularly concerning since taurine is widely consumed as a dietary supplement due
to its many purported health benefits. Indeed, in a project supported by the Office of Dietary Supplements (ODS)
Research Scholars Program, we recently reported that when provided prophylactically, dietary taurine-derived
sulfide can enhance the microbiota’s resistance to invading pathogens. However, in the context of pre-existing
inflammation, such as periodontitis, taurine-derived sulfide may instead exacerbate disease. In this ODS
administrative supplement, we propose testing this exact possibility. Falling within the scope of our original
award, we propose testing whether by a similar mechanism as the cysteine/methionine-degrading pathogen F.
nucleatum, the taurine-degrading pathogen Bilophila wadsworthia can enhance periodontal disease. This new
information will enhance our original award because it will demonstrate that sulfide’s negative impact on oral
health is not restricted to a specific periodontal pathogen (not only F. nucleatum but also B. wadsworthia) nor a
specific sulfide precursor (not only cysteine/methionine but also taurine). Most importantly, the new information
that will be generated by this administrative supplement will shed light on the potential health risks of a widely
consumed dietary supplement (the amino acid taurine) and a context (the prevalent disease periodontitis) in
which consumption of this supplement should be avoided.

Public health relevance
PROJECT NARRATIVE (for administrative supplement to parent R00 award from NIDCR) Taurine, a sulfur-containing amino acid that is highly abundant in mammalian tissue, is widely consumed as a dietary supplement. However, members of the microbiota, including pathogenic members of the oral-cavity microbiota, can degrade taurine to the pro-inflammatory molecule hydrogen sulfide. The goal of this administrative supplement is to determine whether dietary taurine-derived hydrogen sulfide can aggravate periodontal (gum) disease, which, as the most prevalent inflammatory disease worldwide, is a leading cause of tooth loss and numerous co-morbidities.